Shared Resource Management

SHARED RESOURCES MANAGEMENT – PROJECT SUMMARY
The mission of the University of Virginia Cancer Center (UVACC) Shared Resources is to provide high quality,
value-added support for UVACC Members as aligned with the goals of the UVACC. The management of the
Shared Resources is focused on effectively managing the Shared Resources; ensuring that the Shared
Resources meet the scientific needs of the UVACC Members; and planning for future directions and needs of
the UVACC for Shared Resource support.
At the last renewal of the UVACC, seven Shared Resources were submitted including Advanced Microscopy
Facility (AMF) (Scored Outstanding to Excellent), Animal Models of Disease Core (AMDC) (Scored Excellent),
Bioinformatics Core (BIC) (Scored Very Good to Excellent), Biomolecular Analysis Facility (BAF) (Scored
Outstanding), Biorepository and Tissue Research Facility (BTRF) (Scored Very Good to Excellent),
Biostatistics Shared Resource (BSR) (Scored Outstanding to Excellent), and Flow Cytometry Core (FCC)
(Scored Excellent to Outstanding). In the current submission, the UVACC also proposes seven Shared
Resources. However, in response to the requests from UVACC Program Leaders, and based on suggestions
from the last review and external reviewers, the UVACC reorganized and enhanced the Animal Models of
Disease Core to include additional protocols and technology for studying immune response in cancer and
cancer therapy and renamed the core the Molecular and Immunological Translational Sciences Core (MITS).
Given that most of the bioinformatics efforts are in association with support of the data-intensive platforms
present in the BAF (such as DNA and RNA sequencing, proteomics and metabolomics) the BIC is now
embedded within the BAF. To support researchers in the Cancer Control and Population Health Program
(CPH), we have added one Shared Resource, the Population Health and Cancer Outcome Core (PHCOC).
These changes in structure, along with focused improvements to the Shared Resources per the
recommendations of the last review, position the UVACC Shared Resources to provide exceptional expertise,
support, and education for Members' pursuit of cancer research as aligned with the mission of the UVACC.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.